NICHD SUPPORT FOR LONGITUDINAL COHORT OF THE NATIONAL SURVEY OF CHILDREN'S HEALTH

The National Survey of Children’s Health Longitudinal Cohort (NSCH-LC) is primarily sponsored by the Maternal and Child Health Bureau of the Health Resources Services Administration (HRSA MCHB), and co-sponsored by Eunice Kennedy Shriver National Institute of Child Health and Human Development, U.S. Department of Health and Human Services.
The NSCH-LC aims to collect and provide data on the physical and emotional health of 3- to 24-year-olds in the United States with a focus on the COVID–19 pandemic. The NSCH–LC will collect information related to the health and well-being of children, young adults, and their families, including access to and use of health care, family interactions, parental health, school, and after-school experiences. Data will be collected through survey on the internet or questionnaires distributed and re-collected in the mail. The NSCH–LC sample will consist of 60,000 households that responded previously to the National Survey of Children's Health (NSCH) annual survey.
Source from: https://www.federalregister.gov/documents/2023/07/25/2023-15685/agency-information-collection-activities-submission-to-the-office-of-management-and-budget-omb-for